Role of mitochondria in cardiac ischemia

Summary Heart failure is a leading cause of mortality worldwide. Myocardial infarction has been proved to be the most common cause of heart failure. The effective therapeutic strategies need to be developed for the prevention and treatment of myocardial infarction. Apoptosis is a type of death form in myocardial infarction. In order to maintain the heart intact in both structure and function, it is necessary to prevent apoptosis so that the heart does not lose cardiomyocytes. It is well known that cardiomyocytes are enriched in mitochondria. Mitochondria on one hand supply energy for the heart function, they on the other hand participate in the initiation of apoptosis. The most recent studies have revealed that mitochondrial abnormal fission plays a critical role in the regulation of apoptosis. However, the role of mitochondrial fission in the cardiac diseases has been less studied. Furthermore, the molecular regulation of mitochondrial fission in cardiomyocytes remains largely unknown. Our long term goal is to study the role of mitochondria in cardiac pathophysiology. Prohibitin is a cardiac abundant protein. The function of prohibitin in the heart has not yet been clarified. miRNAs are involved in the regulation of cardiac physiology and pathology, but it is unknown whether miRNAs are able to regulate mitochondrial fission machinery. We have made observations clearly showing that prohibitin and miRNA levels are altered in response to oxidative stress and cardiac ischemia. Furthermore, prohibitin can prevent mitochondrial fission and apoptosis in cardiomyocytes. We hypothesize that miRNA and prohibitin constitute an axis in the regulation of mitochondrial fission and apoptosis in the heart. Studies under aim-1 and aim-2 will characterize whether prohibitin can be targeted by the miRNA, and their roles in mitochondrial fission and apoptosis. Studies under aim-3 will explore the molecular mechanism by which prohibitin regulate mitochondrial fission and apoptosis. Studies under aim-4 will test whether prohibitin can influence myocardial infarction induced by ischemia/reperfusion. This proposed project will not only help understand mitochondrial fission and its molecular regulation in the heart, but also can lead to further studies to develop the innovative approaches for the interventional treatment of apoptosis-related cardiac diseases such as myocardial infarction.

Public health relevance
Project Narrative Heart failure is a leading cause of mortality worldwide. Myocardial infarction has been proved to be the most common cause of heart failure. The effective therapeutic strategies need to be developed for the prevention and treatment of myocardial infarction. Apoptosis is a type of death form in myocardial infarction, it is thus necessary to prevent apoptosis in the heart. Cardiomyocytes are enriched in mitochondria. However, mitochondria on one hand supply energy for the heart function, they on the other hand participate in the initiation of apoptosis. The most recent studies have revealed that mitochondrial abnormal fission plays a critical role in the regulation of apoptosis. Our proposed project is expected to reveal the role of mitochondrial fission in the cardiac apoptosis. The obtained results can lead to further studies to develop the innovative approaches for the interventional treatment of apoptosis-related cardiac diseases such as myocardial infarction. __SpecificAimsTextDelimiter__ Specific Aims Cardiomyocyte apoptosis is a death form in the heart, and involved in a variety of pathophysiological conditions including myocardial infarction, cardiac hypertrophy and heart failure 1-11. The heart function stringently depends on the ATP-generating pathway 12, and it is therefore enriched in mitochondria. The highly abundant existence of functional mitochondria in the cardiomyocytes is essential for supplying energy required for normal cardiac contractile function 13. However, because mitochondria contain a variety of proapoptotic factors such as cytochrome c14 and Smac/Diablo15, 16, the enrichment of mitochondria in cardiomyocytes on the other hand, indicates the tendency of cardiomyocytes to undergo apoptosis through mitochondrial pathway. Mitochondria constantly undergo fusion and fission that are necessary for the maintenance of organelle fidelity 17. Strikingly, most recent studies have revealed that abnormal mitochondrial fusion and fission participate in the regulation of apoptosis 17-23. Mitochondrial fusion is able to inhibit apoptosis, while growing body of evidence reveals that the mitochondrial fission is necessary for initiation of apoptosis. Hitherto, it remains largely unknown as to whether the abnormal mitochondrial fission plays a role in the pathogenesis of cardiac diseases. In particular, it is not yet clear whether mitochondrial fission is related to cardiomyocyte apoptosis. The process of mitochondrial fission is regulated by an evolutionarily conserved protein, dynamin- related protein (Drp1)24, 25. In healthy mammalian cells, endogenous Drp1 is predominantly localized in the cytosol and it can be translocated into mitochondria during apoptosis. Overexpression of dominant negative Drp1 protein results in dramatic increase of mitochondrial connectivity24, while overexpression of Drp1 promotes mitochondrial fission and increases cell vulnerability26, suggesting that Drp1 is a critical component of the mitochondria fission machinery. The Drp1 gene is highly transcribed in skeletal muscle, heart, kidney and brain25. Our previous work has shown that the function of Drp1 in mitochondrial fission can be counteracted by the cardiac abundant anti-apoptotic protein27. Our recent work has revealed that Drp1 is involved in mitochondrial fission in cardiomyocytes28. Thus, the available molecular and cellular evidence together demonstrate that Drp1 plays a vital role in controlling mitochondrial fission. However, it remains largely unknown as to how Drp1 function is regulated in apoptosis. MicroRNAs (miRNAs) are a class of small non-coding RNAs that mediate post-transcriptional gene silencing. miRNAs are able to regulate apoptosis in tumor cells. Given the important role of miRNAs in regulating cardiac diseases29-39, it is necessary to understand the role of miRNAs in regulating cardiac apoptosis. However, there have been so far only few publications showing that miRNAs can regulate cardiac apoptosis. A recent report demonstrates that in H9c2 cells miR-1 is proapoptotic, and miR-133 is antiapoptotic29. The molecular mechanism by which miRNAs regulate cardiac apoptosis remains unknown. In particular, it is not yet clear whether miRNAs are involved in the regulation of mitochondrial fission machinery. Prohibitin is a mitochondrial protein40, and its function and role in mitochondrial fission remain largely unknown. There is evidence revealing that prohibitin is related to apoptosis. Enforced expression of prohibitin can inhibit serum withdraw- and staurosporin-induced apoptosis41. Prohibitin controls cell proliferation and apoptosis by regulating cristae morphogenesis in mitochondria42. Intriguingly, prohibitin is abundantly expressed in the heart 40, but its function in heart remains to be elucidated. Also, it is not yet clear whether prohibitin and Drp1 has a cross-talk in the mitochondrial fission machiney. Our preliminary studies have shown that prohibitin and miR-128 are altered in cardiomyocytes in response to oxidative stress and in the heart exposed to ischemia. Furthermore, prohibitin is able to prevent mitochondrial fission and apoptosis in cardiomyocytes. In addition, miR-128 can be a potential regulator of prohibitin. Based on these novel observations, we hypothesize that "miR-128 and prohibitin constitute an axis in the regulation of mitochondrial fission and apoptosis in the heart''. We will test this through studies under the following specific aims. AIM-1: To characterize whether prohibitin is a target of miR-128 AIM-2: To elucidate whether miR-128 and prohibitin constitute an axis to regulate mitochondrial fission and apoptosis AIM-3: To explore the molecular mechanism by which miR-128 and prohibitin regulate mitochondrial fission and apoptosis AIM-4: To test whether miR-128 and prohibitin can influence myocardial infarction in the animal model